Northwestern University Skin Biology and Diseases Resource-based Center

Overall Project Summary
Northwestern University (NU) is renowned for its interdisciplinary cutaneous biology research program, which
focuses on epidermal structure and function. The NU Skin Biology and Disease Resource Center (SBDRC)
adopts the theme "Keratinocyte and its Microenvironment" to promote exceptional basic and translational
research. With 41 Senior Bench members, 8 Junior Bench members, 1 new non-member P&F Awardee, and
13 Collaborating Clinical Associate members, the SBDRC spans 13 University departments and 5 divisions
within the Department of Medicine. The ultimate goal of the SBDRC is to provide the infrastructure for
discovery that can translate into improved patient care. The SBDRC consists of four cores: Administrative
(Admin), Skin Tissue Engineering and Morphology (STEM), Translating Experimental Skin Testing with
Immune Tracing, Informatics and Technology (TEST IT2 ), and Gene Editing, Transduction, and
Nanotechnology (GET iN). The Admin Core fosters collaboration through its Enrichment Program, Pilot and
Feasibility (P&F) Grants, and the Minority and Sex Awareness (MSA) Program. The STEM Core offers diverse
primary healthy and diseased human skin cells and tissue, but also simple and complex multi-cell 3D human
skin equivalent models using cells from healthy or diseased skin. Cells for models can be modified genetically,
including with inducible gene manipulation, and viewed using innovative tools, such as live imaging. The Core
also offers a range of morphogenetic processing services. Our next generation TEST IT2 Core provides state-
of-the-art single-cell and spatial genomic tools with a focus on interactions between keratinocytes and other
cell types, such as immune cells, fibroblasts, melanocytes, and nerve afferents. The Core offers immunological
assays and the unique opportunity for controlled human testing. Skin-specific bioinformatics pipelines and
resources for investigator-initiated projects are available. The GET iN Core generates a broad range of viral
constructs and provides nonviral delivery techniques using nanotechnology, such as spherical nucleic acids
and high-density lipoprotein (HDL)-like nanoparticles, as well as electroporation. The Core offers
CRISPR/Cas9 gene knockout, a genome-wide CRISPR screen, and epigenomic approaches (CRISPRa and
CRISPRi). The STEM, TEST IT2 , and GET iN Cores collaborate internally and with other University Cores to
provide education, technical services, and interpretation of results. The NU SBDRC is well-positioned to offer
users the opportunity to translate their basic findings into animal and human cell models, as well as the clinical
setting, empowering skin biologists at NU and beyond to significantly advance our understanding and
treatment of skin disease.

Public health relevance
Overall Narrative The SBDRC enhances research in cutaneous biology at Northwestern University and throughout the U.S. by providing networking and learning opportunities, advanced technology for performing studies, and shared data, thereby attracting new investigators into skin research. The Administrative Core, with its Enrichment, Pilot Grant, and Diversity-focused Programs, and the Research Cores will foster cooperative interactions among scientists and between scientists and clinicians, which will translate into innovative research, discovery, and ultimately better health care for patients with skin diseases.